Predicting and Identifying Risk Factors for Short Time at Home in Older Adults after Hospitalization

ABSTRACT
The time after hospitalization is a critical window for older adults recovering from acute medical problems.
Roughly 1 in 5 Medicare beneficiaries are discharged from hospital to skilled nursing facilities (SNFs) for post-
acute care and rehabilitation, accounting for over 2 million stays annually. Although SNF stays are intended to
restore independence and function, many patients cycle between re-hospitalizations and SNF in a downward
spiral. Time at home quantifies this phenomenon of being ‘rehabbed to death’ by counting the number of days
spent alive in the community, out of the hospital or SNF. However, tools that assess risk for short time at home
have not been developed in the SNF setting, and identifying these can inform the design of interventions.
Frailty is a common state of vulnerability known to increase risks of hospitalizations and mortality
among older adults. Although rehabilitation interventions improve function and outcomes among non-frail
adults in outpatient settings, frail compared to more robust older adults do not benefit from the same
rehabilitation approaches. Moreover, whether modifiable risk factors such as delirium, depression, and
potentially inappropriate medications (PIMs), independently impact short time at home in the setting of frailty is
unclear. Thus, frailty measures have the potential to risk-stratify rehabilitation patients for short time at home
while informing targeting of meaningful and efficacious interventions.
This proposal aims to elucidate predictors of short time at home after SNF discharge among well-
established frailty measures and modifiable risk factors. This research will leverage an existing dataset of a
nationally representative cohort of Medicare beneficiaries, the National Health and Aging Trends Study
(NHATS) linked to Medicare claims. The specific aims are to: 1) Assess and compare the ability of two
measures of pre-hospitalization frailty to predict short time at home after post-acute SNF rehabilitation, in a
nationally representative cohort of Medicare beneficiaries, and 2) Identify modifiable risk factors (delirium,
depression, PIMs, rehabilitation characteristics) that are independently associated with short time at home after
post-acute SNF rehabilitation.
IMPACT: This award will support the principal investigator’s (PI’s) early career development and pathway to
becoming a national leader in geriatric post-acute SNF rehabilitation. As a geriatrician with experience in aging
research, Dr. Shi will acquire new insight and perspective from rehabilitation medicine and develop the skills to
design and lead multidisciplinary SNF rehabilitation interventions. This proposal is supported by a collaborative
team of highly experienced mentors and a rich research environment. The research and training will provide
the PI with foundational knowledge in longitudinal data analysis, risk stratification, and modifiable risk factors
for short time at home after SNF rehabilitation. In doing so, it will lead to the next logical step: designing and
evaluating a tailored intervention guided by the frailty status of older patients, maximizing their time at home.

Public health relevance
PROJECT NARRATIVE Although over 20% of older adults receive rehabilitation in nursing homes after hospitalizations, many are re- hospitalized, need long-term care, or die, reducing time at home, a critical patient-centered measure of quality of life. This project is relevant to public health by using frailty measures to identify high-risk older adults and elucidate modifiable risk factors for short time at home after rehabilitation. This informs future work in improving rehabilitation for older adults and optimizing for patient-centered outcomes in skilled nursing facilities.